A Uniquely Scalable Platform for Sequencing Tens of Millions of Single Cells from Complex Clinical Samples with a Streamlined Workflow

PROJECT SUMMARY/ABSTRACT
Single-cell sequencing (SC-seq) has revolutionized our understanding of cellular heterogeneity,
gene expression, and disease mechanisms. However, its adoption in clinical and translational
research remains limited due to throughput constraints, complex workflows, and sample
preparation biases. Sansimeon is addressing these limitations by developing a high-
throughput, streamlined platform for scalable single-cell sequencing. This innovative system
integrates automated workflow for direct analysis of peripheral whole blood and dissociated
tissue.
Our goal is to deliver an end-to-end solution capable of processing large-scale single cell
experiments, with applications in diagnostics, rare cell detection, drug discovery, and cancer
therapy development. We leverage novel microfluidic technologies to achieve unmatched
throughput and data fidelity while preserving cells’ native states. The project will validate this
system in clinically relevant samples and optimize its computational tools to support scaled single-
cell datasets. These efforts aim to advance clinical research and accelerate the adoption of single-
cell sequencing in healthcare and drug development.

Public health relevance
PROJECT NARRATIVE This project addresses critical barriers to the routine use of single-cell sequencing in clinical and translational research by developing a scalable, high-throughput platform for analyzing tens of millions of single cells per experiment. By enabling efficient processing of peripheral whole blood and dissociated tissue with improved cell retention and streamlined workflows, this technology preserves cellular integrity and reduces biases in gene expression data. The platform has the potential to transform clinical diagnostics, rare cell detection, and drug development, directly contributing to improved health outcomes and advancing the understanding and treatment of complex diseases.